Functional genetic analysis of epigenetic age acceleration and the regulatory landscape of the methylome

DNA methylation (DNAm) shows significant variation between individuals and is altered by aging. The DNAm-
based estimate of biological age (DNAmAge; aka, “epigenetic clock”) is a robust and widely used biomarker of
aging, but its underlying mechanisms remain mostly unknown. The rate at which the epigenetic clock ticks,
commonly referred to as epigenetic age acceleration (EAA or DNAmAge-acc), is a measure of the rate of
biological aging and is predictive of health and life expectancy, and modifiable by diet. We have found that
EAA varies significantly between mouse strains belonging to the BXD family, and is a highly heritable trait that
is linked to strong QTLs. Strikingly, the QTLs we have uncovered for EAA in the BXDs, overlap loci and
candidate genes that are also associated with EAA in humans. These include genes such as Stxbp4, Nkx2–3,
and Cutc. In Aim 1a, we will perform CRISPR/Cas9 based gene deletion of few of these candidate genes in
mouse fibroblast cells. We will use cells derived from the two parent strains of the BXDs (C57BL/6J, and
DBA/2J). If gene deletion or knockdown is found to have an impact on the epigenetic clock, we will follow-up
with deep sequencing of the transcriptome (Aim 1b) to gain deeper insights into the associated gene
expression changes and potential mechanisms. In Aim 2, we will apply integrative systems genetics to define
the genetic variants that contribute to variability in the larger methylome by performing methylation QTL
(meQTL) analyses. This will be carried out in a larger panel of the BXD recombinant inbred and advanced
intercross strains that will give us sufficient power for QTL detection. Aim 2 will leverage an existing resource
of biobanked liver specimens. From preliminary work, we have found that some of the highly variable CpG
regions in the liver are significantly correlated with body weight, and with strain differences in life expectancy.
We will chart the networks of cis- and trans-acting genetic variants that configure the methylome in a highly
metabolic tissue (i.e., liver), and examine whether these cis and trans-meQTLs also relate to complex traits
such as body weight, and natural variation in lifespan. Furthermore, these liver samples already have multi-
omics datasets (transcriptomics, proteomics, and metabolomics), and this will add an epigenomic layer that will
facilitate multi-scalar integrative analyses. Together, the two aims will shed light on the genes that regulate the
epigenetic clock, and the genetic variants that contribute to shaping the larger methylome. Additionally, we will
be able to study how these epigenetic traits associate with, and possibly mediate, downstream molecular traits
such as gene expression, and higher order traits such as body weight, metabolism, and longevity.

Public health relevance
This proposal will take a two-pronged approach to develop a deeper understanding of the mechanisms that modulate the epigenetic clock, and the genes that underlie variation in DNA methylation. First, we will carry out focused functional genomic assays using CRISPR/Cas9 to test key candidate genes and examine if manipulating these genes result in changes in the intrinsic rate of epigenetic aging in mouse cells. Second, we will perform genome-wide genetic mapping analyses to chart the vast regulatory landscape of the methylome, and examine how the genetic variants that contribute to DNA methylation relate to phenotypes such as body weight and longevity.